Predicting the hemodynamic response to mitral valve interventions with pressure-volume analysis

Project Summary: The proposed K23 development award will enable Dr. Michael Brener to become an
independent investigator in the field of valvular heart disease (VHD). Dr Brener is an interventional cardiologist
and plans to use this training to conduct research where invasive hemodynamics are acquired to better
diagnose and manage individuals with VHD. A team of thought leaders with expertise mentoring early career
investigators will guide Dr. Brener to develop his skillset in the field of research using cardiovascular imaging,
deep learning for analysis of longitudinal, hemodynamic, and imaging data, and prospective trial design.
Focused coursework, experiential learning, and mentored meetings will supplement conduct of the proposed
research, which focuses on mitral regurgitation (MR). MR is the most common form of VHD and represents a
significant public health concern. A minimally invasive technique called mitral transcatheter edge-to-edge
repair (mTEER) was recently shown to reduce mortality and heart failure (HF) hospitalizations for patients with
functional MR (FMR), which is a form of MR that arises as a byproduct of left ventricular (LV) dysfunction.
However, patient selection for this procedure is challenging because the standard of care diagnostic studies
fail to adequately capture the extent of LV dysfunction in the context of FMR. The proposed research uses a
novel technique, traditionally employed in preclinical studies, called pressure-volume (PV) analysis to provide a
more accurate representation of LV function. The specific aims of the proposed research are to (1) identify new
echocardiographic measures of LV systolic function (LVSF) in individuals with severe FMR that are correlated
with PV loop derived measures of LVSF, (2) characterize the association between baseline LVSF and changes
in LV function immediately after mTEER using PV analysis, and (3) assess the relationship between immediate
changes in LV function after mTEER and a sustained, longitudinal hemodynamic response as determined by
an implantable device called a wireless pulmonary artery pressure sensor (wPAP-S). These aims will be
accomplished within the framework of the randomized controlled CardioClip trial, where 60 individuals with
FMR will undergo mTEER and be randomized to the usual post-procedural care vs. implantation of a wPAP-S.
The data generated by the proposed research will provide the granular hemodynamic foundation needed to
better understand LV function in FMR and elucidate the physiologic underpinnings for changes in patient-
reported outcomes and clinical events after mTEER. These efforts will help Dr. Brener transition to research
independence and provide much-needed evidence to change clinical practice by addressing critical knowledge
gaps in VHD and help reduce VHD-associated mortality.

Public health relevance
Project Narrative: One out of every five patients with heart failure suffers from significant functional mitral regurgitation (FMR). An inadequate understanding of left ventricular (LV) function in the context of FMR prevents clinicians from identifying good candidates for FMR intervention. The proposed research will address these knowledge gaps by using a novel technique called pressure-volume analysis to develop a new paradigm for evaluating LV function in patients with FMR that will optimize patient selection and help clinicians predict the hemodynamic and clinical response to therapy.